GENDER-SPECIFIC T CELL HOMING AND AUTOIMMUNITY

DESCRIPTION: (Adapted from the applicant's abstract) - Women are more susceptible to autoimmune diseases, and the reason is unknown. Female sex hormones appear to play a role in this predisposition to autoimmunity, but extensive analysis of the effects of the female sex steroids on immune responses in vitro have failed to identify the mechanism(s). Dr. Richardson's group has used a new model of drug- induced lupus to identify novel gender-specific immune mechanisms. In this model, D10 cells, a cloned Th2 line, are made autoreactive by treatment with a mitogen and DNA methylation inhibitors, then injected into syngeneic mice. The autoreactive cells cause a more severe autoimmune disease in females than in males, and disease severity is diminished by oophorectomy. Significantly more of the cells, treated or untreated, accumulate in the female spleens, and this selective retention also decreases following oophorectomy. Finally, splenectomy prevents the development of autoimmunity. These results demonstrate that T cell splenic homing differs between males and females, and that the spleen is essential for the development of the disease. These results suggest that the greater disease severity in females is due to more autoreactive cells accumulating in the female spleens. The observation that these effects are reversed by oophorectomy implicates female sex hormones in these differences. Dr. Richardson hypothesizes that gender- specific differences in T cell homing, due to effects of female sex hormones on adhesion molecule expression, contribute to increased severity of autoimmune diseases in females by modifying lymphocyte trafficking patterns. Gender-specific trafficking differences could be important both in the induction of disease as well as later in the disease process. Dr. Richardson's model provides a unique opportunity, he believes, to test the role of sex hormones directly in modulating endothelial cell adhesion molecule expression and lymphocyte homing, and to relate these findings to the development and severity of autoimmunity. The specific aims are to (1) characterize the effects of sex hormones on T cell homing in vivo; (2) define the effects of sex hormones and other signals on T cell and endothelial cell adhesion expression and function in vitro; and to define the role of these adhesion molecules whose expression is modified by sex hormones in splenic homing and in disease processes. Dr. Richardson anticipates that these studies will identify novel and important mechanisms contributing to the increased incidence and severity of autoimmune disease in women.